Role of Factor XII in Thrombo-Inflammatory Complications of Sickle Cell Disease

PROJECT SUMMARY - ABSTRACT
The overall goal of this proposal is to characterize Factor XII (FXII) functions in sickle cell disease (SCD) and
their contribution to venous thrombosis (VT), vaso-occlusive crisis (VOC) and end-organ injury. SCD is a
hematologic disorder caused by a single nucleotide mutation of the β-globin gene. Hypoxia-induced sickling of
red blood cells (RBCs) results in painful recurrent VOC, hemolytic anemia and cumulatively, in multi-organ
damage. A chronic hypercoagulable state with increased risk of venous thrombosis contributes to increased
morbidity and mortality among patients with SCD. New targeted anticoagulant therapies are still associated with
increased rates of bleeding.
We previously demonstrated that FXII contributes to the development of VT through both its enzymatic (FXIIa)
functions as well as the thromboinflammatory effects of zymogen FXII-mediated activation of urokinase
plasminogen activator receptor (uPAR) on neutrophils. Recently, we found that patients with SCD exhibit
chronically enhanced FXII activation compared to healthy controls. Moreover, we showed that FXII expression
is elevated in SCD neutrophils, and that FXII contributes to neutrophil activation and adhesion in SCD.
Importantly, treatment with an anti-FXII antibody that blocks both zymogen and enzymatic functions of FXII(a)
significantly attenuated experimental VT and microvascular stasis in a murine model of SCD. These findings
support the central hypothesis that FXII contributes to vaso-occlusion and VT in SCD through distinct cellular
and molecular mechanisms.
Using clinical samples and well-established murine model of SCD together with novel pharmacologic and genetic
approaches, our goals in this application are to: i) identify disease-specific triggers of FXII activation; ii)
characterize FXII effects on neutrophil functions; iii) investigate the relative contributions of different cellular
sources, and compare the zymogen versus protease functions of FXII in vascular stasis and VT; iv) determine
the effect of long-term FXII deficiency on disease progression and early mortality associated with SCD. Our goal
is to delineate the mechanisms by which FXII and its downstream effectors drive SCD pathologies, which will
lay the foundation for future therapeutic approaches to inhibit FXII.

Public health relevance
PROJECT NARRATIVE Deep vein thrombosis and vaso-occlusive crisis (VOC) are taking a staggering toll on sickle cell disease (SCD) patients. We are taking a new approach based on basic research and advanced technological tools to inhibit the different functions of Factor XII. This approach has a strong potential to inhibit prothrombotic complications as well as attenuate VOC in a safer manner that does not cause bleeding.